Sensing and Clearance of Damaged Lysosomes in Macrophages and Atherosclerosis

Project Summary / Abstract
Atherosclerosis is the underlying cause of the majority of cardiovascular diseases leading to tremendous
morbidity and mortality. The macrophage plays a significant role in atherosclerotic plaque progression and recent
efforts to identify the culprit cellular processes in macrophages have renewed interest in the role of the
autophagy-lysosomal system. Various lines of evidence demonstrate a progressive dysfunction in the lysosomes
of plaque macrophages which affects their ability to clear lipids and apoptotic cells. Thus, attempts at
reprogramming the degradative capacity of macrophages might be a fruitful therapeutic area. Our work with
TFEB, the predominant transcription factor regulating autophagy-lysosomal biogenesis, shows that enhancing
its function in macrophages is atheroprotective. We have recently determined that a critical sensor for lysosomal
damage in macrophages which acts to activate TFEB and autophagy is Galectin-3 (Gal3). Gal3 has traditionally
been known as a biomarker for cardiovascular disease and a secreted protein with roles in immune cell
recruitment and promoting atherosclerosis. However, its intracellular role is likely protective by facilitating
autophagy-lysosomal function. In addition, we have shown that macrophage inflammasome activation and
ensuing pyroptosis is a major trigger for Gal3 release on par with IL-1β secretion. This raises the interesting
possibility that interventions aimed at curbing Gal3 release could be dually beneficial by preventing deleterious
extracellular functions while retaining it in macrophages to mediate the lysosomal damage response. In this
proposal, we aim to test the hypothesis that the Gal3-TFEB/autophagy axis in macrophages ameliorates
atherosclerosis by mediating the sensing, clearance, and replacement of damaged lysosomes. We will
evaluate this in three aims with the first aim assessing the role of Gal3 in macrophage lysosomal damage
response, the second aim assessing the mechanism of Gal3 release with the goal of shifting the balance toward
its beneficial intracellular roles, and the third aim evaluating the relevance of these mechanisms in human
monocytes/macrophages.

Public health relevance
Project Narrative Atherosclerotic vascular disease remains the leading cause of death in the United States with the majority of mortality due to coronary artery disease and myocardial infarction. Macrophages are primary cells that specialize in removing the excess lipids and other debris present in the atherosclerotic plaque. They accomplish this using a robust degradative system called the lysosome which is known to become progressively dysfunctional with advancing atherosclerotic disease. We have discovered critical components of the response to remove and replace damaged lysosomes in order to reduce atherosclerosis and identified Galectin-3 as a critical link between the sensing of lysosome dysfunction and triggering this response. In this proposal, we will evaluate the intricate roles for Galectin-3 and the lysosomal damage response in macrophages derived from mouse models and humans with cardiovascular disease. This work will uncover ways in which one can leverage and stimulate the degradation machinery in macrophages in therapies aims at ameliorating cardiovascular disease.